Evaluating macrophage antiviral immunity as a suppressive factor in SIV-M. tuberculosis co-infection

PROJECT SUMMARY:
A third of the world’s population is infected with Mycobacterium tuberculosis (Mtb), the bacterium that causes
tuberculosis (TB). The human immune system is highly successful at controlling Mtb and immunocompetent
individuals who are infected have a 5-10% lifetime chance of experiencing active (symptomatic) TB. This level
of protection is mediated by cytokine-based cell-cell communication in granulomas, the lesions associated with
TB. Factors that dysregulate the protective Th1 responses, including downregulation of the macrophage activat-
ing cytokines IFNγ and TNF, can promote active TB. HIV significantly increases the risk of developing TB and
HIV-Mtb coinfected individuals experience a 5-15% annual risk of developing active TB and TB is a leading killer
in this population. This elevated risk occurs in individuals who have normal range peripheral CD4+ T cell numbers
and well controlled virus loads. Studies in SIV-Mtb coinfected nonhuman primates (NHPs), which are the best
available model of HIV-Mtb coinfection, show that granulomas from coinfected and Mtb-only animals contain
similar numbers of Mtb-specific T cells. These data suggest that virus-associated T cell-independent factors
promote TB in SIV/HIV+ individuals. Macrophages may be the key to understanding the pathology of HIV-Mtb
coinfection. Macrophages can support Mtb replication but are also the primary anti-Mtb effector cell in granulo-
mas. Our preliminary data using RNAscope indicates that macrophages in NHP granulomas are infected with
SIV and transcriptional analysis of granulomas from SIV+ and SIV- monkeys shows that coinfected granulomas
have increased expression of type 1 interferon (IFN1) transcripts. IFN1s are induced by viral infection but are
also associated with exacerbated TB, and based on these data, we hypothesize that viral infection induces IFN1-
regulated immunity in granuloma macrophages and this suppresses macrophage antimycobacterial immunity,
thus promoting TB. This hypothesis cannot be tested in humans and murine models are experimentally tractable
but have significantly different immunobiology, HIV susceptibility, and TB presentation than humans. To over-
come these obstacles, we will use highly multiplexed cyclic IHC and RNAscope on FFPE NHP granulomas to
identify the relationship between IFN1, SIV infection, and macrophage anti-Mtb activity in SIV/Mtb coinfection.
These studies will be done on a unique set of NHP granulomas with known Mtb and SIV loads, and we will use
computational image analysis and machine learning to identify SIV+/- cells, how SIV affects cellular organization,
IFN1 expression, and macrophage activation. To test our findings from these studies, we will use lung granuloma
organoids composed of lung tissue from Mtb-infected macaques, in combination with fluorescent protein ex-
pressing Mtb, SIV and IFN1 inhibition. These studies will identify relationships between SIV-regulated IFN1 ex-
pression and Mtb survival in coinfected granulomas. Our long-term goal is to identify host-directed therapies to
improve outcomes in HIV-Mtb coinfection and the mechanistic studies we are proposing with this innovative and
translational system will produce new information on HIV-TB pathogenesis that contributes to this objective.

Public health relevance
PROJECT NARRATIVE Individuals with HIV-M. tuberculosis coinfection are at severe risk of tuberculosis (TB). The basis for this susceptibility is not known but may be driven a shift away from macrophage antibacterial immunity towards antiviral responses. This project uses high-dimensional imaging and analysis in combination with innovative mechanism-level in vitro studies to identify how viral infection compromises immunity in TB.